Structure-Function Studies of the Human Cytochrome P450 27 Family

Summary
The PI is requesting an administrative supplement to fund the purchase of fast protein liquid chromatography
(FPLC) equipment to aid protein purification, specifically an ÄKTA Go from Cytiva Life Sciences. The instrument
will be used to upscale protein purification throughput to match recent lab advances in recombinant protein
production and enable high-resolution, high-capacity size exclusion chromatography techniques. All experiments
in the original parent award (1R35GM147276) utilize recombinantly produced and purified isolated protein, so
access to the ÄKTA Go FPLC will enhance all aspects of the parent award.

Public health relevance
This administrative supplement is to fund the purchase of fast protein liquid chromatography (FPLC) equipment to aid purification of protein produced recombinantly and used for in vitro research studies. Significant quantities and high purity protein are necessary for experiments regarding the nature of cytochrome P450 enzymes and their roles in generating endogenous hormones and steroids key to regulating human health. The new instrument will allow more types of experiments to be performed than possible with our current equipment and for all work requiring these proteins to be performed more rapidly.